Human endothelial cell regulation of ossification

PROJECT SUMMARY/ABSTRACT
Every year, >1 million patients undergo bone repair procedures in the United States. Autologous bone grafting
remains the preferred treatment for bone defects, but this practice is limited by bone availability and donor site
morbidity. Alternatively, the development of therapies that exploit the osteogenic potential of bone marrow-
derived mesenchymal stem cells (bm-MSCs) continues to be a priority in regenerative medicine. However, efforts
remain largely empirical due to a poor understanding of the mechanisms regulating bm-MSC osteogenic activity
in vivo. Our overarching goal is to elucidate the mechanisms regulating ossification and develop therapeutic
strategies for bone regeneration using autologous bm-MSCs. Previously, we showed that preserving human
bm-MSCs' osteogenic potential depends on sustaining proximity to endothelial cells (ECs). More recently, we
have found that the type of ECs drastically affects bm-MSC fate in vivo. Specifically, vascular networks lined by
human trabecular bone arteriole ECs (tba-ECs) could spontaneously induce osteogenic differentiation of bm-
MSCs. In contrast, non-bone ECs could not. Our Preliminary Data suggest that the expression of KITLG drives
this unique osteoinductive potential. Indeed, silencing KITLG in tba-ECs completely abrogated osteogenesis
upon implantation in vivo, whereas overexpressing KITLG in non-bone ECs conferred robust osteoinductive
properties. Our data also suggest that KITLG expression in tba-ECs is regulated by type I interferon (IFN)
signaling, a previously unknown link. Our central hypothesis is that a constitutive IFN-KITLG mechanism drives
the distinct osteoinductive properties of human tba-ECs. We also postulate that educating induced pluripotent
stem cells (iPSCs) could offer a plentiful source of surrogate tba-ECs, eliminating the need for harvesting
autologous bone. To test these hypotheses, we propose three specific aims. In Aim-1, we will dissect the
mechanism by which human tba-ECs mediates osteogenesis via KITLG expression. We will determine which
KITLG isoform (soluble vs. membrane-bound) is indispensable and dissect the role of recruited c-Kit+
hematopoietic progenitor cells (c-Kit+ HPCs) in osteogenesis. In Aim-2, we will determine the molecular
mechanism that regulates KITLG expression in human tba-ECs. We will use a CRISPR/Cas9 loss‐of‐function
approach to silence components of the type I IFN pathway and unravel the interactions between IFN signaling
mediators and the enhancer-promoter region of the KITLG gene. In Aim-3, we will pursue strategies to educate
human iPSC-derived ECs to acquire osteoinductive function, including transient activation of KITLG and IFN
signaling. In summary, these studies will define the cellular and molecular mechanisms by which human tba-
ECs regulate the osteogenic differentiation of bm-MSCs and, in turn, ossification. This fundamental knowledge
will form the foundation for strategies to promote bone repair and regeneration.

Public health relevance
PROJECT NARRATIVE Bone grafting remains the preferred treatment for bone defects, but this practice is limited by donor site morbidity. Alternatively, we seek to develop therapies that exploit the bone-regenerating potential of a specific type of bone marrow-derived stem cells. Here, we propose studies to understand how blood vessels regulate these human stem cells' activity, paving the way to more rational therapeutic strategies in the regeneration of bone defects.